The role for cell cycle regulators in trichloroethylene induced Parkinson's dementia

Project Summary
The purpose of this NIH F31 application is to obtain support for the PI, Ashley Adamson, to carry out mentored
research and career development activities such that the PI obtains the necessary experience and training to
become a rigorous independent researcher. The project goal is to leverage the PI’s current skillset with a rigorous
training program to position her to study the key proteins, pathways, and mechanisms behind environmentally
caused neurodegenerative diseases, namely Parkinson’s disease dementia. The primary objective of this
research proposal is to investigate the role of cell cycle regulatory proteins in facilitating cognitive impairments
caused by trichloroethylene exposure in the context of Parkinson’s disease dementia. Work from the lab of Dr.
Briana De Miranda, the PI’s sponsor, has shown that exposure to trichloroethylene inhalation induces
nigrostriatal dopaminergic neurodegeneration, motor deficits, and alpha-synuclein accumulation in mice.
Furthermore, the PI showed that trichloroethylene exposure induces cognitive deficits congruent with those
commonly observed in Parkinson’s disease. However, it is currently unknown by what mechanisms
trichloroethylene facilitates these deficits. This project aims to increase our understanding of the mechanisms by
which cognitive impairment is induced by trichloroethylene exposure by evaluating the roles of aberrant CDK5
activation in pathogenic protein accumulation (Aim 1) and increased cellular senescence in neural stem cell
populations (Aim 2). The long-term objective of the PI’s research is to identify the role for environmental
exposures in influencing the significant heterogeneity of cognitive symptomology in Parkinson’s disease, and to
identify disease modifying therapeutic strategies to stop the progression of the disease.
The proposed training plan for Ashley Adamson is sponsored by Dr. Briana De Miranda and co-sponsored by
Dr. Erik Roberson. The overall goal of the training plan is to provide Ashley with the conceptual and technical
skills necessary to establish a strong foundation for a career in academic research. The training plan has been
developed with activities to foster Ashley’s training in 3 crucial areas: 1) conceptual and technical research,
including studies in neurodegeneration, cognition, and neurotoxicology; 2) statistical rigor, reproducibility, and
transparency; including preparation in ethical research practices; and 3) career development, including training
in mentorship, teaching, and scientific communication. This proposal will uniquely prepare the PI to conduct
rigorous hypothesis-driven research in neurotoxicology and neurodegenerative disease while also curating the
skills necessary for a becoming a competent scientist, teacher, and mentor in academic science.

Public health relevance
Project Narrative Though cognitive impairments occur in up to 80% of all Parkinson’s disease cases, no therapies exist targeting this symptomology and no mechanisms have been proposed for the significant heterogeneity in presentation and onset timing. The proposed research will investigate the role for environmental toxicants in influencing cognitive impairments, and specifically assess the role of aberrant CDK5 activation and increased cellular senescence in driving pathogenic protein accumulation and adult neurogenesis impairment following TCE exposure. This work will increase understanding of cognitive impairments in Parkinson’s disease, ascertain TCE’s mechanism of action, and identify potential therapeutic targets for slowing disease progression and alleviating disease burden caused by Parkinson’s disease dementia.